Modulation of Network Feedback Shifts the Locus of Rhythm Generation

Central pattern generator (CPG) networks control important rhythmic behaviors such as chewing, breathing,
and locomotion. CPGs must continuously adapt to physiological and environmental challenges, conveyed via
sensory pathways, to maintain healthy function. Dysfunction of CPGs or their inputs due to neurological
disorders or stroke-induced damage alters CPG function and adaptability, which decreases health and quality
of life. One way in which CPG networks adapt is through changes in the spatial distribution of their active
components, such as mammalian respiratory CPG activity varying along a brainstem column. However, little is
known about the cellular-level mechanisms by which sensory pathways trigger changes in the spatial
distribution of CPGs, and how such changes may alter the mechanisms of rhythm generation. Sensory
pathways influence CPGs directly or by activating projection neuron inputs to CPGs. Projection neuron activity,
which is further regulated by synaptic feedback from their target CPGs, determines CPG output. CPG
feedback strength is flexible, and feedback can link different nervous system regions. Thus, the central
hypothesis of this proposal is that sensory modulation of CPG feedback can alter rhythm generation
locus and mechanism. Small invertebrate neural networks have enabled much insight into network plasticity
due to having fewer neurons with well-described connectivity, and complete CPGs that can be maintained in
vitro. In this proposal, an in vitro stomatogastric nervous system (STNS) preparation from the crab (Cancer
borealis) will provide exceptional access to identified sensory, chewing CPG, feedback, and projection
neurons. Sensory activation of distinct chewing rhythms, photoinactivation of identified neurons and neuronal
compartments, hybrid computational-biological networks, and independent manipulation of local and distant
synaptic actions of a feedback neuron will be used to identify cellular and synaptic mechanisms controlling
rhythm generation locus in different modulatory states. It is expected that a novel mechanism for altering CPG
spatial distribution will be identified, namely modulation of CPG feedback strength and incorporation of this
feedback into rhythm generation. It is further predicted that altering rhythm generation locus in this manner is a
novel mechanism for regulating the access of sensory pathways to a motor system. An increased cellular-level
understanding of the dynamics of rhythm generation locus is important for future investigation into how
damage or dysfunction may change CPG adaptability. Identifying novel principles in a small well-defined
system will guide studies of interactions between sensory and CPG feedback pathways that regulate CPG
spatial distribution in larger nervous systems during both functional and dysfunctional states. Further, this
proposal will provide research and networking opportunities for students, including experience in cutting-edge
electrophysiological techniques, quantitative data analysis skills, and oral and written scientific communication
skills, helping to fill a large, unmet demand for neuroscience research opportunities at Miami University.

Public health relevance
Central pattern generator (CPG) networks underlying important rhythmic behaviors such as breathing, chewing, swallowing, and locomotion must adapt to physiological and environmental challenges to maintain health and a high quality of life. The proposed project will use a small, well-defined CPG to identify novel cellular-level mechanisms that determine which nervous system regions generate rhythmic activity in order to adapt to changing demands. Greater understanding of the flexibility of CPG networks can lead to treatment for disruptions in rhythmic behaviors caused by neurological disorders and stroke-induced damage in CPGs or their inputs.